Objective assessment of vocal fatigue in laboratory and real-world settings

Project Summary/Abstract
Approximately 30% of US adults are affected by a voice disorder during their lives, with about 25 million people
experiencing a voice disorder at any given point in time, resulting in societal costs (lost work, medical expenses,
etc.) estimated at $13.5 billion annually. Vocal fatigue (VF) is viewed as an etiological and/or reactive component
in most common voice disorders and is also among the most common voice-related complaints of individuals
who rely on their voices to make a living (e.g., teachers, singers, etc.). Previous definitions of VF have varied
with a recent attempt at consensus describing VF as a multifaceted concept that involves an individual’s self-
perceived symptoms (e.g., increased effort and discomfort) and/or a deterioration in vocal function associated
with an individual’s attempt to meet his/her vocal demands. Prior studies have demonstrated high speaker-to-
speaker variability in recovery from VF, but the factors associated with such high variability are not determined.
Unfortunately, there is a paucity of objective information about the causes and impact on phonatory mechanisms
of VF, limiting efforts to prevent and clinically manage this common complaint.
The objectives of this project are (1) to use a multi-modal measurement approach to comprehensively, and
objectively, describe the progressive impact of VF on vocal function, (2) to quantify the underlying voicing-resting
behaviors that contribute to the progression of VF and its recovery, and (3) to identify the vocal function and
vocal behavior parameters that could account for the observed high variability in VF recovery trajectories. The
objectives of this study are pursued using a combination of an existing ambulatory voice monitoring dataset and
new data. The existing dataset includes ambulatory voice recordings from 87 vocally typical individuals (for a
total of 889 days) and 123 patients with vocal hyperfunction (for a total of 763 days). The new data will include
a well-controlled inlab vocal loading protocol, and three days of infield monitoring using a state-of-the-art wireless
monitoring system. The inlab session will include periodic multi-modal data acquisition of vocal function (high-
speed videoendoscopy, aerodynamics, electroglottography, acoustics, and neck-surface accelerometry) during
the progression of the loading protocol. Statistical power of machine learning is combined with two novel
ambulatory measures of vocal fold dissipated energy (reflecting vocal function) and a time series voicing-resting
ratio (the temporal sequencing of phonatory and resting periods reflecting vocal behavior) to quantify progression
and recovery of VF in terms of a person’s prior cumulative vocal behavior and vocal function.
Achieving the goals of this project will lay the groundwork for the development of new clinical tools for preventing,
assessing, and alleviating VF, which will be particularly valuable for professionals in occupations requiring heavy
voice use.

Public health relevance
Project Narrative Vocal fatigue (VF) is among the most common voice-related complaints among individuals who rely on their voices to make a living (teachers, singers, etc.) and is implicated as an etiologic and/or reactive component in most common voice disorders. This project will use a combination of an existing ambulatory voice monitoring dataset and newly acquired data to quantify vocal function and behaviors that are associated with the causes and impact on phonatory mechanisms of VF among patients with voice disorders and vocally typical individuals. Achieving the goals of this project will lay the groundwork for the development of new clinical tools for preventing, assessing, and alleviating VF, which will be particularly valuable for professionals in occupations requiring heavy voice use.